Aerocyte-mediated Alveolar Epithelial Regeneration following Lung Injury

PROJECT SUMMARY / ABSTRACT
Acute Respiratory Distress Syndrome (ARDS) is a life-threatening lung injury caused by various factors
such as infection and trauma, currently lacking a cure. Annually, approximately 190,000 Americans are
diagnosed with ARDS, a number further amplified by the COVID-19 pandemic. The primary pathology involves
damage to the alveolar epithelium, necessitating innovative approaches to accelerate alveolar epithelial
regeneration for treating ARDS.
Alveoli, surrounded by abundant capillaries for gas exchange, remain poorly understood in their regulatory
role within this intensive capillary niche. Our focus is on aerocytes, a recently identified capillary endothelial
population specialized in the lungs and positioned on the outer surface of the alveolar epithelium. Given
this unique location, we propose that aerocytes play a pivotal role in alveolar epithelial regeneration. Preliminary
data indicate that aerocytes express the angiocrine factor R-spondin3, a Wnt signaling activator, and stem cell
factor. Loss of angiocrine R-spondin3 impedes regenerative epithelial remodeling and lung repair following injury,
suggesting a crucial role for aerocyte-derived signaling in lung alveolar regeneration.
Our research proposal aims to establish the central role of aerocytes in regulating alveolar regeneration
post lung injury, with a specific focus on the signaling molecule R-spondin3. We hypothesize that aerocytes
guide regenerative alveolar remodeling through R-spondin3, enhancing Wnt signaling in alveolar
epithelium, and orchestrating interstitial macrophage plasticity for the necessary regenerative niche. To
rigorously test this hypothesis, we outline the following specific aims:
Aim 1: Investigate the role of aerocyte-derived R-spondin3 in lung growth and recovery using loss-of-
function and gain-of-function animal studies within disease-related lung injury models.
Aim 2: Define the mechanisms of regenerative alveolar remodeling guided by aerocyte-derived signaling,
focusing on AT2 cell renewal, transition into TSCs, and differentiation into AT1 cells using advanced techniques
such as alveolar organoids.
Aim 3: Examine the impact of aerocytes on interstitial macrophage plasticity in establishing a
regenerative alveolar niche.
By unveiling the role and mechanisms of aerocytes in alveolar epithelial regeneration, this research
potentially leads to innovative therapeutic strategies for treating ARDS by targeting aerocyte-derived signaling
to regenerate the alveoli, ultimately improving the health and quality of life for individuals affected by severe
respiratory complications associated with COVID-19 and ARDS.

Public health relevance
NARRATIVE Acute Respiratory Distress Syndrome (ARDS) is a life-threatening lung injury associated with critical illnesses like sepsis, trauma, and severe COVID-19, lacking a current cure. The core pathology involves damage to the alveolar epithelium, necessitating innovative approaches to accelerate alveolar epithelial regeneration for treating ARDS. This study aims to investigate the role and mechanisms of aerocytes in regulating alveolar epithelial regeneration following acute lung injury, aiming to identify novel therapeutic targets for treating ARDS and addressing the critical need for effective interventions in this life-threatening condition.